Magnetic Resonance Spectroscopy Biomarkers of Neurodegeneration

DESCRIPTION (provided by applicant): The long-term goal of this project is to establish non-invasive magnetic resonance spectroscopy (MRS) biomarkers that are sensitive to progressive neurodegeneration and its reversal. To accomplish this with high sensitivity and specificity, high field scanners (3 tesla and higher) are utilized. The focus of the application in this first cycle is hereditary spinocerebellar ataxias (SCAs), which provide the ideal neurodegenerative disease model because their diagnoses can be genetically confirmed, the patient populations are well characterized and they offer transgenic mouse models that faithfully reproduce the pathology and phenotype of the human disease enabling translation of findings between pre-clinical and clinical trials. Furthermore, various treatments are currently entering the pipeline for SCAs and their testing in clinical trials may benefit immensely from objective surrogate markers. In this respect, a recently established SCA Consortium will provide the opportunity to utilize the technology in clinical trials because high field scanners are available at each participating site. Recent work demonstrated that 1) high fields enable acquisition of cerebellar neurochemical profiles from patients with SCAs and transgenic mouse models of SCA type 1 (SCA1) with excellent reproducibility; 2) SCA1, SCA2 and SCA6 can be distinguished by neurochemical signatures; 3) alterations in MRS biomarkers correlate cross-sectionally with disease severity in patients with SCA1 and longitudinally with pathology in SCA1 mice and 4) alterations in MRS biomarkers are partially-to-completely reversed in a conditional SCA1 mouse model upon suppression of transgene expression. Studies are proposed to further validate proton MRS (1H MRS) as an outcome measure in pre-clinical and clinical trials. The specific aims are: Aim # 1) To determine if disease progression can be monitored by 1H MRS by measuring cerebellar and brainstem neurochemical profiles longitudinally over 5 years in early- moderate stage patients with SCA1. Aim # 2) To identify the 1H MRS biomarkers that reflect disease severity in patients with SCA2, SCA3 and SCA6 and to determine if MRS biomarkers are disease specific by a cross- sectional comparison of neurochemical differences in early-moderate stage patients with SCA1, SCA2, SCA3 and SCA6 relative to healthy controls. Aim # 3) To determine if neurochemical levels measured by 1H MRS accurately reflect the extent of recovery from neurodegeneration following complete and partial suppression of transgene expression by evaluating neurochemical levels, mRNA levels of ataxin-1 and pathology simultaneously in the cerebella of conditional SCA1 mice.

Public health relevance
PUBLIC HEALTH RELEVANCE: This work intends to establish non-invasive, quantitative imaging measures of biochemical and cellular alterations in neurodegenerative diseases. Such measures can eventually be used in the clinic for early disease detection, which will facilitate application of treatments to delay the onset of these diseases, and for monitoring disease progression and treatment response. Successful application of such treatments is expected to reduce the burden caused by these diseases on individuals, their families and society. RELEVANCE: This work intends to establish non-invasive, quantitative imaging measures of biochemical and cellular alterations in neurodegenerative diseases. Such measures can eventually be used in the clinic for early disease detection, which will facilitate application of treatments to delay the onset of these diseases, and for monitoring disease progression and treatment response. Successful application of such treatments is expected to reduce the burden caused by these diseases on individuals, their families and society. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Successful implementation of therapies for neurodegenerative diseases will be greatly aided by the establishment of objective and robust biomarkers, to detect early disease prior to irreversible neuron loss in patients known to have a specific mutation and to monitor disease progression and treatment effects. In this respect, the potential utility of magnetic resonance spectroscopy (MRS) has been demonstrated repeatedly. MRS enables non-invasive quantification of endogenous neurochemicals that may reflect neuronal and glial abnormalities associated with neurodegeneration. However, MRS studies have typically measured concentrations of 3 metabolites (N-acetylaspartate (NAA), creatine, choline) or their ratios at 1.5 tesla (T) scanners where measurement errors are high due to limited sensitivity. Furthermore, a common observation in neurodegenerative diseases has been a decrease in NAA levels or the NAA/creatine ratio, making the MRS findings non-specific. Both sensitivity and specificity issues can potentially be overcome by utilizing higher magnetic field scanners, where profiles of 10-18 neurochemicals can be quantified in affected brain regions thanks to the increased sensitivity and resolution. While high field scanners (3T and higher) are now available at almost all major medical schools and clinical research centers, comprehensive investigations of the benefits of high fields for clinical applications of MRS are lacking, posing a critical barrier to progress. Specifically, we still need to determine if the neurochemical levels obtained at high field can be used to non-invasively assess progressive neurodegeneration in patients (Aim #1), if neurochemical profiles afford disease-specific neurochemical signatures (Aim #2) and if they accurately reflect reversal of pathology upon treatment (Aim #3). To move the field forward we have chosen to focus our efforts on a set of hereditary movement disorders, spinocerebellar ataxias (SCAs), which are characterized by neurodegeneration in the cerebellum and in most cases also the brainstem. SCAs are an ideal neurodegeneration model to test the specificity and sensitivity of high field MRS biomarkers. First, well-characterized patient populations with known rates of disease progression (as assessed by a validated clinical scale) facilitate testing of the sensitivity of MRS biomarkers to disease progression. Second, multiple genetic forms with confirmed diagnoses and overlapping clinical presentation allow testing of the specificity of MRS biomarkers to different diseases. Lastly, transgenic mouse models that faithfully reproduce pathological and clinical aspects of the human disease, most notably a conditional model with which reversibility of neuronal and motor dysfunction was demonstrated, enable testing of the sensitivity of MRS biomarkers to disease reversal. Our preliminary data show that 1) high fields enable acquisition of cerebellar neurochemical profiles from patients with SCAs and transgenic mouse models of SCA type 1 (SCA1) with excellent inter- (in patients) and intra-subject (in mice) reproducibility; 2) SCA1, SCA2 and SCA6 can be distinguished by neurochemical signatures; 3) alterations in NAA, glutamate and myo-inositol correlate cross-sectionally with disease severity in patients with SCA1 and longitudinally with pathology in SCA1 mice and 4) NAA and myo-inositol alterations are reversed in a conditional SCA1 mouse model upon suppression of transgene expression. The objectives of this application are built on the strength of these preliminary data and pursue the next steps for validating MRS as an outcome measure in pre-clinical and clinical SCA trials. Our specific aims are: Aim #1: To test the hypothesis that disease progression can be monitored by proton (1H) MRS longitudinally in early-moderate stage patients with SCA1 at 3T. Disease progression will be measured by the Scale for the Assessment and Rating of Ataxia (SARA) and correlated to MRS measures. Aim #2: To identify the 1H MRS biomarkers that correlate with clinical status (SARA) in SCA2, SCA3 and SCA6 and to test the hypothesis that MRS biomarkers differ among SCA subtypes by a cross-sectional comparison of neurochemical differences in early-moderate stage patients with SCA1, SCA2, SCA3 and SCA6 relative to healthy controls at 7T. Aim #3: To test the hypothesis that 1H MRS biomarkers accurately reflect the extent of recovery from neurodegeneration using a model for treatment at 9.4T. For this, transgene expression will be completely or partially suppressed in conditional transgenic SCA1 mice, which will provide a model for complete or partial reversal of pathology, and the response of MRS markers will be correlated with residual transgene expression (as quantified by mRNA analysis) and residual pathology (as assessed by semi-quantitative histology). The proposed work is innovative because the benefits of high field, non-invasive MR technology will be systematically assessed to establish the validity of MRS biomarkers as outcome measures in clinical trials of neurodegenerative diseases, starting with SCAs. The application is also very timely in light of the recent establishment of the Clinical Research Consortium for Spinocerebellar Ataxias, formed to provide infrastructure for future clinical trials in SCA1, SCA2, SCA3 and SCA6. The MRS technology will be transferred to the participating sites, all of which have high field scanners (see Resource Sharing Plan). Thus, the work proposed here together with the infrastructure provided by the Consortium will enable utilization of the technology in clinical trials in the near future.